Administrative Core

Abstract Administrative Core
The Administrative Core of The Scripps Research Institute-Alcohol Research Center (TSRI-ARC) provides
leadership and an organizational framework to meet the Center’s Specific Aims. Center-wide scientific aims in
the renewal are focused on the cellular and molecular mechanisms that modulate top-down medial prefrontal
control of the central amygdala and underlie stress-induced vulnerability to relapse and excessive drinking during
protracted abstinence. The Administrative Core facilitates Center-wide direction, oversight, and integration
across 5 Research Components (Functional Connectomics, Neuropharmacology, Molecular, Neurophysiology,
and Neurocircuitry), and 3 Cores (Dissemination, Animal Models, and Neuroproteomics). Specific Aims are: (1)
Provide scientific and administrative leadership for TSRI-ARC Cores and Research Components to
function in an optimal and synergistic manner. The Center Director chairs monthly meetings of the Steering
Committee which is comprised of all Project Leads, and with the help of the Scientific Director and Deputy
Scientific Director, monitors progress and outcomes of all projects, develops new collaborations, and identifies
problems and proposes fair solutions. A Program Advisory Committee comprised of five external experts in
domains relevant to TSRI-ARC will meet annually to review progress and make recommendations to the Director.
The Director implements course corrections and the reprioritization of resources when indicated, and dynamically
manages expenditures to bolster TSRI-ARC aims. (2) Facilitate the dissemination of expertise between
Cores and Research Components and the utilization of Core resources. Cores provide systematic
prioritization of resources and standardized methods that foster integration of projects. Rapid dissemination and
utilization of Core expertise (e.g., new animal models, biochemical analyses, single-cell proteomics analysis
techniques, and functional neurocircuitry mapping techniques) are accomplished by monthly Steering Committee
meetings and monthly Center-at-Large scientific seminars. Requests for Core services are submitted (and data
archived) on the TSRI-ARC website, providing transparency of Core operations and facilitating ongoing review
of the Cores’ efficiency by the Steering Committee. (3) Provide scientific enrichment for TSRI-ARC and
disseminate TSRI-ARC research. The Administrative Core will organize monthly scientific seminars to
stimulate collaborations and scientific enrichment throughout the Center-at-Large. Seminars include a
presentation by a project Lead on recent progress, or an invited lecturer on research relevant to TSRI-ARC’s
scientific interests, in tandem with 1:1 meetings with investigators. TSRI-ARC will host an annual Scientific
Retreat on the TSRI campus, consisting of a poster session, a data blitz, and presentations by TSRI-ARC and
Center-at-Large investigators, T32 postdoctoral trainees, and interns. TSRI-ARC discoveries are shared with
scientific, healthcare and lay stakeholders via scientific publications and presentations, our website and social
media, and outreach to youth from health disparities backgrounds who are at higher risk for stress and AUD.